TMJ Disc Regeneration

Patients opting for TMJ disc removal face issues due to the absence of FDA-approved
replacements, leading to bone-to-bone contact and subsequent joint problems. Autografts, like
dermis-fat grafts, typically resorb within a year. Our goal is a secure disc replacement
alternative. Previous studies demonstrated rapid transformation of an acellular ECM scaffold
into TMJ disc-like tissue in canine and porcine models. The canine model, chosen for its hinge-
socket preventing implant migration, lacks human-like motions, and pig models have access
issues. Introducing the goat model, with human-like access and motions, addresses these
limitations. Proposed research focuses on the 12-month clinical endpoint, investigating the
impact of a pathogenic TMJ environment on remodeling a porcine SIS scaffold into a neo-disc in
goats. We aim to determine the long-term (6, 9, 12 months) functional remodeling of SIS
scaffolds in the TMJ, hypothesizing higher tensile moduli than dermis-fat autografts, even in a
pathological environment. Addressing a critical gap in understanding outcomes beyond 6
months is crucial for clinical translation. This work aims to provide a groundbreaking, safe TMJ
disc treatment, preventing joint damage and revolutionizing surgical management for TMJ
patients, with the potential to significantly improve outcomes.

Public health relevance
This proposal describes work in which a biologic scaffold composed of mammalian extracellular matrix will be used as an inductive scaffold for the in vivo generation of the temporomandibular joint disc. This inductive template will stimulate the rapid endogenous formation of a fibrocartilaginous disc that closely mimics the structure, composition and function of native disc material. The proposal will provide the first safe treatment following disc removal, improving outcomes for patients by preventing joint damage from long term bone-on-bone articulation.